CONFERENCE ON THE ROLE OF IMMUNODEFICIENCY IN CANCER

The investigators and staff of the Immunodeficiency-Cancer Registry seek funds to host a conference on the role of immunodeficiency and cancer. The proposed evening conference will be held in conjunction with the annual spring meetings of the Society for Pediatric Research and the Society of Clinical Investigation in Washington D.C., May 1986. The purpose of the conference will be (1) to provide up-to-date information on several major topics pertaining to the association between immunodeficiency and cancer and (2) to explore the relevance of studies in patients with naturally-occurring immunodeficiencies who develop tumors, to cancer in patients with iatrogeneic or acquired immunosuppression as well as "seemingly" nonimmunodeficient persons. Case material from the Immunodeficiency-Cancer Registry will provide an introduction to discussion of the pathophysiological, cytogenetic, and virologic correlates of tumors in patients with naturally-occurring as well as therapy-induced immunodeficiencies. Experts in several areas (e.g., epidemiology, genetics, virology, and/or molecular biology), who have also had experience with immunodeficient patients or their tumors, will be invited to make formal presentations on the state-of-the art and future directions. Several clinicians who have had experience with cancer in immunodeficient hosts will be invited as discussants (rapporteurs). It is hoped that attendees, primarily clinical researchers, will gain new enthusiasm for studying prospective patient material, that new collaborations between basic scientists, pathologists, and clinicians will follow, and that the Immunodeficiency-Cancer Registry, as well as the nonprofit lay organization, Immunodeficiency Foundation, will facilitate these developments.